Development of an Environmental Health Literacy Mobile Application to Reduce Toxic Environmental Exposures in Black Communities

ABSTRACT
Exposures to endocrine disrupting chemicals (EDCs), including bisphenols, phthalates, and parabens, have
been linked to chronic diseases,1–5 and infertility.6,7 Unfortunately, minority and marginalized populations are
disproportionately exposed to and affected by EDCs, due to differences in product use, demographics,
occupations, and lifestyle, largely stemming from social inequalities.8,9 Mobile phone applications are powerful
tools for education and behavior changes, especially with the incorporation of gamification and instant
feedback.10,11 Currently, there are few mobile apps for raising EDC awareness and reducing environmental
exposures. The goal of this proposal is to develop the FIRST mobile application (app) and education
program, MEET, by providing Minority-focused Environmental health Education and Tracking on topics
pertaining to environmental exposures targeted to a minority population, assessing this population’s routine
exposures via an app-based mobile exposure journal which documents lifestyle, diet, and product use and
provide personalized exposure reduction recommendations, and tracking environmental health literacy
(EHL) and lifestyle improvements over time. Our app will provide real-time feedback in response to user
entries, so that individuals can make effective, evidence-based changes. We will achieve these goals by
implementing the following three aims: 1) identify lifestyle behaviors and products in a minority population that
may contribute to harmful exposures through focus groups and interviews; 2) develop culturally appropriate
educational EDC EHL materials and recommendations to reduce exposures by collaborating with community
members to add to and adapt Million Marker’s (MM) existing extensive online educational resources and
recommendations; and 3) integrate developed educational materials and targeted recommendations into the
existing MM app and test the usability of the app as well as changes in EHL, readiness to change, and
products and practices using in a cohort of 100 community members. Completion of this project will allow MM
to empower individuals in minority communities to increase their EHL and reduce their harmful exposures. This
Phase I SBIR funding will allow us to develop and begin testing the feasibility of our minority population-
targeted app, and improve MM’s products and services. If the aims are achieved, we will be ready for Phase II
to further evaluate the efficacy of this program, and scale and adapt it to multiple minority/marginalized
populations.

Public health relevance
Project Narrative Currently, there are few mobile apps for raising endocrine disrupting chemical (EDC) awareness and reducing environmental exposures which provide only static general guidelines and consumer product information, and offer limited personalization, interaction, and feedback. Further, none of these apps are designed for use by minority populations and have several systemic barriers (i.e., language, cultural, knowledge, economic) for use by such populations. This work aims to develop a multicultural mobile phone application and environmental health literacy (EHL) materials for raising EDC awareness and literacy and reducing environmental exposures. We propose to do this by assessing a population of African Americans’ routine exposures and providing personalized exposure reduction recommendations (via science-backed research and focus groups); providing culturally appropriate, personalized, interactive environmental health education pertaining to environmental exposures targeted to a minority population; and tracking EHL and lifestyle improvements over time. Completion of this proposal will allow Million Marker to empower individuals in minority communities to increase their EHL and reduce their harmful exposures. This Phase I SBIR funding will allow us to develop and test the feasibility of a multicultural app and improve MM’s product and services. If the aims are achieved, we will be ready for Phase II and further evaluate the efficacy of the app and services, and extend it to other minority/marginalized populations.